Ferroptosis and Polyunsaturated Fatty Acid Metabolism

Project Summary: The overall goal of our research program is to develop chemical tools and an in vivo pipeline
to delineate mechanisms of ferroptosis regulation by endogenous oxidized polyunsaturated fatty acids (PUFAs).
Ferroptosis is a recently discovered iron-dependent non-apoptotic programmed cell death that is characterized
by an increase in membrane lipid peroxidation. Like other programmed cell death, ferroptosis has a broad impact
on cell and embryo development, cell senescence, tissue homeostasis, and many diseases. Several key proteins
and compounds that regulate ferroptosis have been identified, but the underlying mechanism of ferroptosis and
its endogenous mediators are poorly understood. This proposal is based on our research centered around PUFA
oxidative metabolism and health. Our research focuses on generating novel chemical tools to investigate the
mechanism of PUFA metabolites on human health. Specifically, we have developed multiple synthetic methods
to prepare cytochrome P450 (CYP) PUFA metabolites. We also designed and synthesized the corresponding
PUFA novel mimics. We applied these synthesized metabolites and mimics to identify many new biological
effects of PUFA CYP metabolites. To investigate the mechanism behind the biological effects of CYP PUFA
metabolites, we established C. elegans as a novel biological model in our lab due to the vast genetic tools
available and the adaptability for high-throughput screening. All of these features greatly facilitate mechanistic
studies. Using C. elegans, we found that endogenous PUFAs and the corresponding CYP metabolites induce
ferroptosis only in the germline and neurons. Based on these findings, our central hypothesis for this
proposal is that PUFA metabolites are endogenous lipid mediators of ferroptosis. To significantly advance
the understanding of this novel programmed cell death, this R35 will address two questions: 1) What are the
endogenous signaling molecules of ferroptosis? And 2) How is ferroptosis regulated in a cell type-specific
manner? In the next five years, we will use PUFA metabolites, metabolite mimics, and metabolic inhibitors that
we will synthesize in combination with a novel model organism (C. elegans) and their vast genetic tools to answer
our scientific questions by 1) identifying endogenous PUFA metabolites that trigger or inhibit ferroptosis and 2)
developing a novel in vivo platform to delineate cell-specific ferroptosis regulatory pathways.
Understanding how oxidized PUFA metabolites trigger ferroptosis in specific cell types will have implications for
how ferroptosis may affect human health. The outcomes from this proposal will build a strong foundation for our
future research on multiple levels. The identified lipid mediators and protein targets will be further tested in
mammalian models for research translation and mechanistic studies. The discovery of lipid mediators and protein
targets also allows us to develop drug candidates to treat diseases related to ferroptosis. The developed
transgenic strains and in vivo platform will allow us to identify novel signaling molecules or protein targets that
regulate cell-type specific ferroptosis. We will continue to develop novel chemical tools to investigate ferroptosis.

Public health relevance
Project narrative Our investigation of the crosstalk between ferroptosis and polyunsaturated fatty acid metabolism will lead to a better understanding of the role of polyunsaturated fatty acid metabolites in programmed cell death that will have huge implications on human physiology and may identify novel treatments for many diseases. Specifically, we will combine synthetic metabolites and mimics as powerful chemical probes, state-of-the-art analytical tools, genetic tools, and a novel model organism to delineate how polyunsaturated fatty acid metabolites regulate ferroptosis. Our preliminary data and data from others suggest that specific polyunsaturated fatty acids trigger ferroptosis and inhibition of polyunsaturated fatty acid metabolism rescues ferroptosis triggered by specific polyunsaturated fatty acids illustrating that particular polyunsaturated fatty acids or their metabolites could have a major role in ferroptosis.